Noninvasive assessment of in vivo tissue loads following treatment of volumetric muscle loss

PROJECT SUMMARY/ABSTRACT
Volumetric muscle loss (VML) is a debilitating condition that leads to chronic functional impairment
due to the irrecoverable loss of muscle tissue. There are no physical rehabilitation or surgical
standards of care for VML. As such, there is a critical need to develop therapeutics for muscle
regeneration. Animal model studies have shown that increased mechanical loading of muscle via
electrical stimulation or wheel running is a promising strategy for partially restoring function.
Specifically, electrically stimulated eccentric contraction (ESEC) training where the muscle-tendon
unit is elongated while the muscle is contracted has been most promising. Regardless of the
therapeutic approach to treating VML, and even more broadly to muscle function in general, there
are no techniques for noninvasively and directly measuring the in vivo force generating capacity
of muscle in animals. Shear wave tensiometry has recently been introduced as a noninvasive
technique for assessing in vivo muscle-tendon loading in humans. Loading is quantified by
tracking the vibrational behavior of propagating shear waves. While this technology has proven
useful in assessing muscle-tendon loading across a range of human health conditions, it has not
been scaled or evaluated in animal models, although it holds substantial potential in this context.
Accordingly, our overall objectives are to (1) develop a small animal tensiometer capable of
measuring reductions in in vivo muscle forces due to injury, and (2) determine the effectiveness
of ESEC on improving muscle force generation following injury. In Aim 1, we will develop a shear
wave tensiometer that integrates with our established rodent ankle dynamometer. Following VML
to the lateral gastrocnemius in a rodent model, wave speed via tensiometry and ankle torque via
dynamometry in injured animals will be compared to controls throughout recovery. This will mark
a pivotal first step in validating the effectiveness, accuracy, and reliability of tensiometry against
established methodologies in the field. In Aim 2, using the same VML model, ESEC will be applied
after injury to assess its effectiveness on improving functional and histological outcomes.
Successful completion of these aims holds dual significance. First, we will have validated the use
of tensiometry as a noninvasive, direct measure of in vivo muscle function in small animal models.
Long-term, we envision this technology as a wearable sensor to characterize muscle loading in a
wide range of animal models of disease, injury, development, and aging. Second, we will show
that ESEC training has the potential to make significant improvements in muscle function following
VML. This will set the stage for investigating synergist treatment strategies for VML when
combined with complementary therapeutics such as biomaterials or drugs.

Public health relevance
PROJECT NARRATIVE Volumetric muscle loss is the irrecoverable loss of muscle tissue that leads to life-long dysfunction or permanent disability. Current treatment options are extremely limited, and there are no physical rehabilitation or surgical standards of care. Using an animal model, the goal of this research is to develop a novel sensor to assess a promising treatment for volumetric muscle loss.